Rapid Neural Typing Interface for Veterans with ALS

Intracortical brain-computer interfaces (iBCIs) record and decode neural signals to enable fast,
accurate and intuitive control of assistive technologies for Veterans and others living with paralysis
arising from spinal cord injury, stroke, or amyotrophic lateral sclerosis (ALS). Using an intracortical BCI,
people with tetraplegia have been able to use their imagined hand and finger movements to command
point-and-click actions on a computer, type with a virtual keyboard, use communication apps such as
chat, and browse the web. Recently, a person with tetraplegia used the investigational BrainGate iBCI,
and specifically a decoder that could detect the attempted, individual movements of all 10 digits, to play
songs (sequences of individual notes) using an on-screen piano keyboard. Remarkably, imagined left
and right hand and digit movements could be decoded with high accuracy from neural signals recorded
from a single hemisphere of motor cortex. Building on these observations, this project aims to develop
a novel, intuitive neural typing interface for high-throughput communication by Veterans with ALS. The
research hypothesizes and evaluates several methods by which digit and hand decoding could be
combined to achieve direct neural control of a multi-row on-screen keyboard and simultaneous
trackpad actions that would dramatically increase communication rates for individuals with paralysis. To
further enhance neural decoding of imagined simultaneous bilateral hand and digit movements, this
project will leverage motor cortical signals recorded from both hemispheres. Achieving effective and
reliable neural decoding of intended, dexterous finger movements will require expanding current
understanding of the encoding principles of neuronal firing and field potentials from both hemispheres –
separately and in interaction – and creating new areal interaction models for the control of volitional
bimanual actions. This project will assess the relationship between neural encoding of discrete
digit/hand actions associated with imagined typing and encoding of point-and-click actions associated
with continuous on-screen mouse control. To facilitate rapid switching between continuous mouse
actions and rapid neural typing, we will seek latent spaces that characterize these actions in motor
cortical activity and identify approaches to maximally disambiguate these two modes for optimal real-
time decoding. This research leverages state-of-the-art machine learning innovations toward a more
capable, reliable, and versatile iBCI to promote independence for Veterans and others with severe
motor and motor impairments.

Public health relevance
For Veterans and others with ALS, maintaining the ability to communicate is imperative. VA research is at the forefront of intracortical brain-computer interface technology (iBCI), an investigational neurotechnology that could improve independence for Veterans and others living with severe speech and motor impairments. iBCIs have enabled individuals with tetraplegia to use computers by thinking about the movement of their own hand, and to control point-and-click actions for on-screen typing, browsing the web and other familiar enabling activities. The main goal of this project is to provide Veterans and others living with paralysis or loss of speech with an intuitive iBCI-based communication interface that seamlessly enables both point-and-click computer interaction and high-performance multi-digit typing based on intended hand and finger movements.